Administrative Core

The objective of this proposal entitled

Public health relevance
RELEVANCE (See instructions): The Administrative Core will interact with the Internal and External Advisory Committees to provide oversight for the projects and cores. The role of this core is diverse it includes science, education, mentoring, administration and communication within the project as well as with the broader UC San Francisco and UC Davis communities.